Stimulating Access to Research in Residency (StARR) - NIAID

The physician-scientist workforce has been an important driver for many of the substantial discoveries in
infectious, immunologic, and allergic diseases over the last two decades. Yet, this workforce has been in decline.
Residency training typically offers little time or support for research. This major gap in the development of
physician-scientists limits the translation of research into the clinical arena. Following a long, independent history
of training successful physician-scientists, in 2018 Duke was awarded an R38 award to establish the Duke NIAID
Scientist-Clinician-Investigator Stimulating access to Research in Residency (Duke NIAID SCI-StARR) program.
The primary goal of this multidisciplinary program is to train physician-scientists in all aspects of biomedical
research in order to cultivate investigators who will lead the development, implementation, and evaluation of new
clinical modalities to diagnose, treat and prevent infectious, immunologic and allergic diseases in children and
adults. Duke NIAID SCI-StARR trains residents from Medicine, Pediatrics, and Surgery in areas along the full
biomedical research continuum (basic/translational, early phase clinical trials and pharmacokinetics, and late
phase clinical trials and outcomes) with a theme of improving health over the life course. The program
comprises four training aims: 1) comprehensive didactics covering basic, translational, and clinical research and
professional development; 2) development and completion of a research project and an individualized career
development plan; 3) establishment of a track record of scholarly activity; and 4) eligibility for board certification
and continuation to subspecialty training. Duke NIAID SCI-StARR leadership includes an Executive Committee
of MPIs Scott Palmer, MD, MHS (Medicine), Rachel Greenberg, MD, MB, MS (Pediatrics), and David Harpole,
Jr, MD (Surgery), along with Residency Program Directors and Program Coordinators from each department.
Duke NIAID SCI-StARR capitalizes on a team of 32 multi-departmental, multi-disciplinary, well-funded, and
experienced faculty preceptors available to all trainees, independent of their clinical department. This renewal
builds on the success of the initial funding period in which 13 residents (3 Medicine, 3 Pediatrics, 7 Surgery)
were trained and requests support for 18-24 months of protected research time for three Resident-Investigators
appointed annually. Unlike PhDs, physician-scientists must spend several years completing clinical training prior
to returning to laboratory research. To bridge this gap, our program provides two years of technician support
after completing the fellowship. Thus, our trainees will be prepared to transition to research-intense fellowship
training, successfully compete for extramural funding to support a path to independence, and become the next
generation of physicians leading and mentoring trainees in clinically-oriented research of allergy, immunology,
and infectious diseases affecting children and adults. Achievement of the program's objectives will continue to
fulfill urgent needs for: 1) academic physician-scientists and mentors in medical schools throughout the country
and 2) innovations and clinical translation of novel strategies to improve human health across the life course.

Public health relevance
There is a paramount need for clinician scientists who are skilled in modern scientific methods and have the background to develop novel approaches to the diagnosis, treatment, and prevention of infectious, immunologic, and allergic diseases in children and adults. The Duke NIAID Scientist-Clinician-Investigator Stimulating access to Research in Residency (Duke NIAID SCI-StARR) Program will continue the successful approach of providing dedicated research time and training to Resident-Investigators from the Departments of Medicine, Pediatrics, and Surgery to foster their maturation into independent physician-scientists who use cutting-edge methods of laboratory and clinical research to pursue long-term academic careers investigating important issues related to human health. Project Narrative Page 7